Facility Management, Maintenance and Operations Core

Project Summary/Abstract:
Core 1 of this UC7 proposal outlines a strategic plan for operational support, personnel support,
and replacement of essential basic scientific equipment within the UAB Southeastern Biosafety
Laboratory, Alabama Birmingham (SEBLAB). Investment in the UAB SEBLAB advances the
UAB and NIAID mission to bring together innovative research technology, infectious disease
models, and dedicated staff to make novel discoveries on the pathogenesis, detection,
treatment and control of emerging infectious diseases. Aim 1 outlines facility maintenance and
operational support required for SEBLAB to foster safe and productive high containment
research programs. Aim 2 highlights critical support needed for highly trained and skilled
personnel to safely and effectively operate this high complexity facility. Aim 3 outlines essential
basic scientific equipment in need of repair/replacement to maintain high quality research
productivity. Upon completion, this project will achieve the following: 1) Support SEBLAB facility
operational expenses; 2) Fund the leadership, administrative, and technical staff involved in
SEBLAB operations, and 3) Replace existing basic scientific equipment needed to execute
groundbreaking research on high containment pathogens.